Role of intestinal microbiome and gut permeability in the development of Kawasaki Disease vasculitis

PROJECT ABSTRACT
The intestinal microbiota influences many biological processes, including gastrointestinal and systemic immune
responses. Alterations in its composition have been associated with the pathogenesis of cardiovascular (CV)
diseases, including Kawasaki disease (KD), an acute pediatric vasculitis, and the leading cause of acquired heart
disease in children in the USA. However, the functional contributions of these alterations remain unknown. Using
a murine model of KD vasculitis, the Lactobacillus casei cell wall extract (LCWE)-induced KD, which mimics
crucial immunopathologic features of human KD, we have generated critical data on the contribution of intestinal
permeability, the microbiota, and microbiota-derived metabolites to the development of vasculitis. We observed
that LCWE-induced KD in mice is associated with alterations in the intestinal microbiota composition, and we
identified specific microbiota members and metabolites that influence the severity of vasculitis. LCWE-injected
mice also exhibit increased circulating levels of trimethylamine N-oxide (TMAO), an inflammatory metabolite
associated with CV diseases, and the blooming of bacteria involved in trimethylamine (TMA) generation.
Blocking TMAO production pharmacologically in mice reduces the severity of LCWE-induced KD lesions,
suggesting a detrimental effect of TMAO in LCWE-induced KD. Conversely, we observed decreased relative
abundance of A. muciniphila in LCWE-injected mice that developed robust CV lesions. Exogenous
supplementation of A. muciniphila or bacteria-derived metabolites short-chain fatty acids (SCFAs) reduce the
severity of LCWE-induced vasculitis. A. muciniphilia and SCFAs stimulate the secretion by intestinal L cells of
glucagon-like peptide 1 (GLP-1), an incretin hormone with beneficial metabolic and anti-inflammatory effects.
Indeed, LCWE-injected mice also exhibit decreased levels of circulating GLP-1. Here, we propose to
characterize the molecular and cellular mechanisms underlying this host and specific bacteria/metabolite
interactions in the development of LCWE-induced CV lesions. We suggest that LCWE-induced changes in gut
microbiota composition lead to increased TMAO production and subsequent immune activation that promotes
vasculitis. We also hypothesize that A. muciniphila, which is significantly reduced in abundance in the gut
microbiota of LCWE-injected mice, is beneficial by promoting GLP-1 production. We will test these hypotheses
by i) Determining the biological role of TMAO in LCWE-induced KD vasculitis and ii) Determining the role of the
A. muciniphila–GLP-1 axis during LCWE-induced KD vasculitis. The integrative strategies proposed herein will
directly address critical gaps in our knowledge of the development of CV lesions in KD, leading to the
identification of novel therapeutic approaches.

Public health relevance
PROJECT NARRATIVE The intestinal microbiota and intestinal permeability profoundly impact local and distant immune responses, including the cardiovascular system. Using a mouse model mimicking Kawasaki disease, we report alterations in the gut microbiota composition associated with the blooming of Proteobacteria and decreased relative abundances of A. muciniphila. Here, we will investigate if these alterations contribute to the development of vasculitis in mice by promoting TMAO and decreasing GLP-1 production.